Admin Core

Project Summary Analysis of Post-COVID-19 Syndrome in Underserved Racial/ethnic Minorities Living with HIV. Long COVID or post-acute COVID (symptoms beyond 3 weeks) and chronic post?COVID syndrome (beyond 12 weeks) are multisystem syndromes and require multidisciplinary approach to address the physical, social, cognitive, psychological, and economic implications of this often persistent, debilitating, new health condition. Approximately 1 in 10 individuals infected with SARS-CoV-2, the virus that causes COVID-19 will develop post- COVID syndrome. A comprehensive study of post-COVID syndrome in minority communities in the US has been largely ignored in the scientific literature. African American and Hispanic/Latinx communities in the US have the greatest burden of COVID-19 infection, hospitalization, and mortality. Therefore, the impact of post-COVID syndrome in these populations could be highly significant. The physical, mental, and economic hardships experienced by minority communities living with HIV/AIDS in US during the COVID-19 pandemic has been disproportionate. It is also unknown how post-COVID syndrome exacerbates racial/ethnic disparities in physical, social, cognitive, psychological, and economic conditions over time and affects the management of HIV disease. Furthermore, we don’t fully understand the hesitancy of ethnic minorities toward the COVID-19 vaccine after health officials have deemed the EUA vaccines largely safe and effective in this population. A comprehensive analysis of post-COVID syndrome in HIV+ patients that includes an examination of their physical, social, cognitive, psychological, and economic conditions as well as the associated management of their HIV disease and vaccine hesitancy overtime, will provide a better understanding of the interventions that are necessary to promote their well-being.

Public health relevance
Project Narrative African American and Hispanic/Latinx communities in the US have the greatest burden of COVID-19 infection, hospitalization, and mortality. Therefore, the impact of post-COVID syndrome in these populations could be highly significant. Findings from the proposed study will form the basis for evaluating HIV infected individuals with history of COVID-19 infection and/or post-COVID syndrome and propose solutions for an appropriate HIV service delivery model.